Molecular characterization of heme-carrying proteins targeted by S. pneumoniae-produced hydrogen peroxide to induce cell death

Project summary
Streptococcus pneumoniae (Spn) colonizes the lungs leading to million cases of invasive pneumococcal
disease (IPD) that results in ∼1 million deaths worldwide annually. To cause IPD, pneumococcus migrates from
the nasopharynx down to the lungs where it causes cytotoxicity. Spn produces several virulence factors but only
a few factors, such as hydrogen peroxide (H2O2), cause cytotoxicity. Experiments using animal models of Spn
disease have demonstrated that production of H2O2 plays a major role during lung colonization and for the
translocation of pneumococci to the bloodstream; therefore H2O2 is essential to cause IPD. The
pathophysiology of IPD includes subcellular mitochondrial damage, and apoptosis in a variety of cell types.
Apoptosis in cell cultures, and in an animal model of Spn pneumonia, required of hydrogen peroxide but details
of this mechanism have not been studied. In a series of breakthrough experiments we recently demonstrated
that Spn-produced H2O2 oxidizes heme-carrying proteins including hemoglobin but also cytochrome C, a
key molecule triggering apoptosis. We have also shown that structural changes induced by H2O2 causes the
release of heme from hemoglobin and cytochrome C. Since mitochondria are essential for cell survival, and the
release of cytochrome C from the mitochondria to the cytoplasm induces cell death, we hypothesize that these
new discovered oxidative reaction between heme-carrying proteins and Spn-produced H2O2 is a key
component of the host-cell response during the cytotoxicity observed in human lung cells and for the
pathophysiology of IPD. Molecular physiological approaches, leveraged by the Molecular Center for Health
and Disease (MCHD), are proposed below to assess this innovative hypothesis. In Aim 1 we will characterize
the molecular and cellular mechanism(s), induced in alveolar and bronchial lung cells, by the oxidation of heme-
carrying proteins. To assess this, we will investigate oxidation of mitochondrial cytochromes using available
proteins and mitochondrial cytochromes purified from human immortalized and human primary differentiated
cells. The specific host cell response induced by Spn-produced H2O2 will be investigated by targeted proteomics,
Western blot, ELISA and FACS. Evidence from these studies will be further supported by whole transcriptome
studies. Aim 2 will focus on the in-vivo consequences of hydrogen peroxide-induced oxidation of heme-carrying
proteins. We will use a mouse model of pneumococcal pneumonia coupled to targeted proteomics, single-cell
RNA-Seq studies along with histological evaluation and ultrastructural microscopy studies, to investigate the
consequences of such oxidative reactions for healthy carriage and lung disease. The mouse model of
pneumococcal disease will be utilized to evaluate the efficacy of a series of scavengers of H2O2 to decrease
H2O2-associated pneumococcal carriage and/or invasive disease. This highly innovative proposal aligns with the
goals of the COBRE program by integrating and leveraging Core B and Core C technologies and capabilities,
mentorship, and resources provided by the MCHD.

Public health relevance
Narrative Streptococcus pneumoniae (Spn) colonizes the lungs that causes millions cases of severe invasive pneumococcal disease worldwide yearly. Spn-produced hydrogen peroxide oxidizes heme-carrying proteins such as hemoglobin and cytochromes and plays a major role for lung colonization and the translocation to the bloodstream. We will investigate the molecular and cellular mechanism, induced by hydrogen peroxide, leading to the pathophysiology of Spn lung disease.